Long-term and Daily Associations among Intersectional Minority Stress, Structural Oppression, and Alcohol Use and Misuse among Sexual Minority Adolescents of Color

PROJECT SUMMARY/ABSTRACT
Disparities in alcohol and other substance (AOD) use and misuse are well documented between sexual
minority adolescents (SMA) and their heterosexual peers. SMA of color also have higher rates of AOD use and
misuse than heterosexual peers of the same race/ethnicity and to some extent their White SMA peers. Daily
stigma and discrimination-related stressors specific to their marginalized identities (i.e., minority stressors,
racism-based stressors) contribute to health disparities among SMA of color. These stressors occur at the
interpersonal level (e.g., discrimination) and are reinforced at the structural level (e.g., anti-gay laws, or racist
institutional policies). Minority stress at a single axis of identity is directly correlated with AOD use and misuse
among sexual and racial/ethnic minority populations. Similarly, structural oppression (i.e., structural
heterosexism or racism) during adolescence has long-lasting health effects, including AOD use and misuse.
However, this work rarely takes an intersectional lens that considers both sexual orientation and race/ethnicity.
Although mounting cross-sectional and recent but limited longitudinal evidence implicates minority stress as a
key contributor to disparities in AOD use and misuse, the prospective, daily, and chronic impact of these
stressors on SMA of color's AOD use and misuse across adolescence is largely unknown. There is also a lack
of research examining the impact of structural oppression on SMA of color's AOD use, how it may play a key
etiological role in accelerating the progression of AOD use and misuse over adolescence, and how it may
impact the long-term and daily associations between intersectional minority stress and AOD use and misuse in
SMA of color's daily lives. In addition, little is known about protective factors between minority stress and AOD
use and misuse, which is needed to inform prevention and treatment interventions. Relying on our
investigator's team methodological, theoretical, analytic, and clinical expertise and pilot work, we propose a
rigorous and innovative study of intersectional stress and structural oppression and how they relate to AOD
use and misuse among SMA of color. Using a measurement-burst design, a combination of longitudinal and
daily diary methods, our aims are to: 1) test the prospective associations between intersectional stress and
structural oppression and AOD use and misuse among a national sample of SMA of color over 2.5 years
(N=950) with 6-month time-points; 2) test the daily associations between within-person fluctuations of
intersectional stress and AOD craving, use, misuse, and problems among the sample over 10-days at each 6-
month time point; 3) test protective and risk factors that attenuate or exacerbate the associations between
intersectional stress and AOD use and misuse over adolescence across the 2.5 years and in daily life. The
results will allow for more precise understanding of minority stress, structural oppression, and AOD use and
misuse in this population and inform clinical assessment and the development of culturally sensitive
interventions for SMA of color.

Public health relevance
PROJECT NARRATIVE: PUBLIC HEALTH RELEVANCE STATEMENT Sexual minority youth of color are at increased risk for alcohol and other substance use and misuse than their same-race heterosexual peers. These health disparities are a major public health concern, especially among adolescents, given the economic, societal, mortality, and morbidity burdens. The project will test the effects of sexual minority adolescents of color's long-term and daily experiences with stigma-related stressors related to their minority and stigmatized identities and structural oppression of states they reside on their alcohol and other substance use in their natural environment and over 2.5 years of adolescence, in order to inform and develop interventions and improve the well-being of sexual minority adolescents of color.